The Role of Vascular MR-Regulated Genes in Vascular Function and Disease

The mineralocorticoid receptor (MR) is an aldosterone (Aldo)-activated receptor that regulates gene transcription
(genomic) and cellular signaling (non-genomic) to control cell functions and regulate blood pressure (BP). MR
activation is increased in resistant hypertension, obesity, heart failure and the elderly. Increased Aldo predicts
high risk of myocardial infarction (MI) and stroke and MR antagonists are protective out of proportion to BP
lowering, supporting kidney-independent mechanisms. MI and stroke are caused by rupture and thrombosis of
inflamed atherosclerotic (athero) plaques. Women are protected from MI and stroke relative to men until
menopause thereby implicating another hormone, estrogen (E2), while obese women with metabolic syndrome
lose premenopausal protection with rising mortality in this growing demographic. We recently showed that MR
in endothelial cells (EC) contributes to vascular inflammation in athero in male mice by inducing leukocyte
recruitment to vessels and expression of ICAM1 and E-selectin (E-sel) and that this is prevented in females. We
also showed that estrogen receptor alpha (ERa) interacts with the MR in ECs, blocking MR regulation of ICAM1
and that EC-MR-KO protects obese females from EC dysfunction. New data shows that ICAM1 expression is
decreased in primary human ECs from females vs males and this is reversed in obese females; that EC-MR
inhibits the non-genomic effect of E2 to increase nitric oxide (NO); and that myeloid (My)-MR-KO decreases
plaque size and inflammation in ApoE-KO mice, leukocyte rolling by intravital microscopy (IVM), and
macrophage expression of EC adhesion ligands. Based on these data, we propose to test the hypothesis that
EC- and My-MR coordinate vascular inflammation in athero and that females are protected by genomic and non-
genomic interactions between MR and ERa. To test this, we have created innovative reagents and methods
including mice with EC-specific deletion of MR, ERa or both and myeloid-specific deletion of MR, each crossed
to athero-prone genetic mouse models; a mesenteric IVM assay to test sex differences in leukocyte traficking;
EC lines with ERa functional mutants; and a biobank of age matched male and female human aortic ECs. Using
these tools we propose 2 specific aims, each using in vitro and in vivo approaches: SA1 explores the genomic
and non-genomic mechanisms by which MR and ERa interact in ECs to regulate leukocyte recruitment and
plaque inflammation and how this mediates sex differences; SA2 determines the role of My-MR in immune cell
trafficking, plaque macrophage phenotype, and sex-differences in myeloid-T cell interactions. Using these
innovative models, methods, and reagents tailored to study sex-differences, this proposal investigates the novel
concept that EC- and My-MR coordinate vascular and immune cell responses to induce leukocyte recruitment
and vascular inflammation in athero. Completion of the aims will identify mechanisms underlying increased
cardiovascular (CV) risk in growing populations with elevated MR activity and for sex differences in CV disease.

Public health relevance
Lay Summary: Heart attack and stroke remain the leading causes of death for men and women worldwide. Clinical observations link the hormone aldosterone with increased risk of heart attack and stroke and the hormone estrogen with protection from heart attack and stroke. Aldosterone action is increased in obesity and aging, the two fastest growing demographics in the USA. This proposal uses innovative approaches to understand how these two hormones interact with one another within blood vessels and in the immune system to contribute to heart disease. The results will help identify new ways to prevent heart attack and stroke in sex-specific ways in the rapidly growing aging and obese populations in which heart disease risk is very high.